Coordination Section

Project Summary – Coordination Section
The role of the Genome Editing Coordination Section will be to manage communication and logistics
associated with Swine SCGE Center. These responsibilities include reporting to NIH and regulatory
agencies when appropriate. These responsibilities also include communication with the Consortium
Members, the DCC, the Program Steering Committee, and appropriate collaborators. These efforts are in
support of creating SOPs for assessment of safety and efficacy of SCGE systems, reagents, or strategies.
Our group is ideally suited to provide this testing due to our unique composition of individuals that are
experienced with pig production, swine biomedical models, operate successful labs that routinely test
cutting-edge genome editing technology, and are associated with world-renowned National Swine Resource
and Research Center (NSRRC).